ASSESS SAFETY, TOLERANCE, PHARMACOKINETICS AND DEV. OF DECR. HIV-1 TO ATV

The goal of this study is to obtain preliminary information about the potential role of ATV in treatment of Human Immunodeficiency Virus infection (HIV).